Cincinnati Climate Change and Health Research Center

OVERALL CENTER
SUMMARY
This P20 application proposes to establish the Cincinnati Climate Change and Health Research Center
(C3HRC). The central theme of our proposed exploratory center is to examine health outcomes of climate
change-driven exposures to heat, pathogenic microbes, and environmental toxicants, and to identify novel
interventions that promote resiliency in vulnerable populations. Our focus is on the climate-related changes
occurring in our own urban area and elsewhere: Rising temperatures, increased precipitation, and extreme
weather (tornadic and flooding) events. Our investigations of climate change-driven exposures and health
outcomes will be translational, with the goal of developing and testing novel interventions in community and
clinical settings. Our attention to vulnerable populations focuses on first responders and low-income as well as
historically marginalized communities. Consistent with the goals of the Climate Change and Health Research
Centers, the C3HRC will: 1) plan and develop sustainable research capacity by establishing centralized
resources and research infrastructure; 2) develop the Center’s thematic focus and transdisciplinary research
activities on climate change-driven impacts on health in vulnerable populations; 3) enable research that develops
into new programs of science and research applications supporting independent investigators; 4) cultivate
authentic partnerships to engage communities most likely to be impacted by climate change in all phases of the
research process; and 5) actively participate in the NIH Research Coordinating Center to Support Climate
Change and Health Community of Practice activities. C3HRC is led by senior, established investigators and a
transdisciplinary team of experts in exposure science, thermal biology, microbial ecology, infectious disease,
epidemiology, pediatrics, internal medicine, allergy and immunology, lung biology, ergonomics, toxicology,
environmental engineering, bioinformatics, biostatistics, health communication, community engagement, and
design, architecture, and planning. Our Plan for Enhancing Diverse Perspectives (PEDP) is woven into all
aspects of the Center. Health equity research will be prioritized in our projects. Training and capacity building
will be addressed by nourishing strong academic-community partnerships; mentoring and supporting junior and
Early Career Investigators; pilot projects and trainee awards; a climate change and health graduate certificate
program; diverse research teams; providing researchers with current information through a seminar series and
newsletter and curated educational materials and grant opportunities. In the 3-year period of this award, the
C3HRC will support one transdisciplinary research project: The impact of extreme heat on mucosal immunity.
The three cores will be: 1) Administrative; 2) Development; and 3) Community Engagement. This proposal builds
on the many strengths of the University of Cincinnati and our community partners to achieve transformative
research that addresses the core elements of the NIH Initiative in Climate Health Research: Health effects
research, intervention research, health equity, training and capacity building.

Public health relevance
Project Narrative Climate change is a fundamental threat to human health and well-being. While its effects are already being felt, the effects of climate change are expected to intensify over the coming decades. The overall goal of this exploratory grant is to develop a climate change and health research center to explore the dynamics between health and climate change-driven exposures to heat, pathogenic microbes, and environmental toxicants, and to develop novel interventions that promote resiliency in vulnerable populations.